Influence of Mycophenolic Acid Pharmacogenomics on Lung Transplant Outcomes

PROJECT ABSTRACT
Lung transplantation is a life-extending therapy for end-stage lung disease, but necessitates life-long
immunosuppression with agents that have narrow therapeutic windows and inevitable side effects. Mycophenolic
acid (MPA) is the antiproliferative agent of choice. Unlike other agents, routine therapeutic drug monitoring (TDM)
is not performed for MPA because it is challenging to measure area under the curve from 0–12 hours (AUC) to
accurately assess pharmacokinetics (PK). MPA levels vary widely among transplant recipients, and excess
levels are associated with adverse outcomes such as neutropenia, which affects >40% of lung transplant
recipients receiving MPA and negatively affects outcomes. This variability is due in part to differences in genes
involved in MPA metabolism and affects outcomes. We previously identified a link between single nucleotide
polymorphisms in SLCO1B3, a key gene in MPA metabolism, and acute rejection and survival in lung transplant
recipients. Although this and other associations are now known, there has been no attempt to incorporate genetic
data into TDM strategies for MPA or develop an evidence-based therapeutic range for MPA in lung transplant
recipients. We are developing a tool that integrates PK, genetic, and clinical data to predict dose-normalized
AUC for lung transplant recipients receiving MPA. This tool will require a single time-point PK measurement and
will provide an easily available tool for MPA PK research and clinical management. Unfortunately, target MPA
AUC ranges have not been defined due to the lack of routine MPA TDM in lung transplant recipients. We
hypothesize that an optimal MPA concentrations provides adequate immunosuppression while preserving
immune cell function, and that MPA level variability has a strong genetic component. Therefore, we will achieve
three aims in this K01 study. (1) Determine a target therapeutic range for MPA in lung transplant recipients. (2)
Identify genetic factors that influence dose-normalized MPA concentration. (3) Establish the relationships
between MPA exposure, genetic polymorphisms, and neutrophil function, which are key factors in innate and
adaptive immune systems. This will improve clinical practice and outcomes in lung transplant recipients by
enhancing drug efficacy and reducing adverse effects. This experimental work is integrated with a
comprehensive career development plan that builds on Dr. Tague’s previous training (MD, Master of Science in
Clinical Investigation, research in genetics and translational medicine) to become an independent investigator in
pharmacogenetics, bioinformatics, statistical genetics, and genetic epidemiology in lung transplantation. The
stated goals will be achieved through excellent mentoring, premium coursework, and training in scientific
communication. The unique resources and infrastructure of Washington University are ideal for the proposed
plan. This K01 will provide the necessary tools to develop into an independent clinician-investigator focused on
the pharmacogenetics of lung transplant immunology who can secure R01 funding.

Public health relevance
PROJECT NARRATIVE Mycophenolic acid, the current anti-proliferative immunosuppression agent of choice for lung transplant recipients, demonstrates extensive variability in both therapeutic effect and adverse drug effects. This project will investigate how genetic and clinical factors regulate mycophenolic acid exposure and effects and how mycophenolic acid exposure correlates with clinical outcomes. We aim to establish recommendations for therapeutic drug monitoring and precision dosing utilizing a patient’s genetic and clinical profile to optimize therapeutic effects and minimize adverse drug effects of mycophenolic acid.